Synergy of lipolysis and lipophagy in alcoholic liver disease

Project Summary/Abstract
My long-term objective is to discover new cellular mechanisms that contribute to alcoholic liver
disease (ALD), a progressive disease leading to non-reversible stages that can be fatal. One of
the early and reversible precursors of ALD is alcoholic steatosis, in which large triglyceride and
cholesterol-rich lipid droplets (LDs) accumulate within hepatocytes, the main functional cell type
of the liver. While LDs are believed to be central to the progression of ALD, the cellular
mechanisms whereby alcohol disrupts the breakdown of these organelles are poorly
understood. To address this important gap in knowledge, this proposal will define the synergy
between two seemingly-distinct processes of lipid droplet catabolism: lipolysis, which utilizes the
cAMP pathway to activate and recruit cytosolic lipases to the LD surface, and lipophagy, which
utilizes membrane trafficking events that lead to LD breakdown by lysosomal lipases.
Preliminary data suggest that lipolysis and lipophagy machinery target discrete, size-based LD
subpopulations, and that small LDs are targeted for direct engulfment by multivesicular bodies
(MVBs) for catabolism through the late endosomal pathway. Thus, the central hypothesis of this
proposal is that EtOH disrupts a sequential mechanism whereby lipolysis acts on large LDs to
reduce their size for direct uptake by endosomal microlipophagy. In Aim 1, I will determine the
role of cytosolic lipases in protecting against ALD progression. In Aim 2, I will determine effect of
EtOH on a sequential “lipolysis-to-lipophagy” pathway and define the mechanisms by which
MVB/endosomes facilitate microlipophagy of small LDs. In Aim 3, I will integrate my previous
expertise with this new knowledge and training to define novel cAMP signaling mechanisms that
support lipolysis and lipophagy to combat alcoholic steatosis. The exceptionally strong research
environment within Mayo Clinic’s Division of Gastroenterology and Hepatology is ideal for this
training. To accomplish these aims, I will receive hands-on training in rodent models of chronic
alcohol consumption, comparative proteomics, and bioinformatics. This new training
complements my current skillset in cell signaling, microscopy, and biochemistry, and provides a
multidisciplinary toolbox to comprehensively assess lipid catabolism in the liver. The proposed
research will integrate my expertise in cAMP/PKA signaling mechanisms from my graduate
school training with my postdoctoral expertise in lipid droplet biology and alcoholic steatosis.
With the help of my mentor, Dr. Mark McNiven, along with a strong research team including two
collaborators and four advisory committee members, I will have all the expertise and training
needed to successfully accomplish these aims and transition to an independent research
position. The results gained from the proposed research will provide a mechanistic
understanding of lipid droplet catabolism in alcoholic fatty liver. Importantly, these studies will
provide published research manuscripts and preliminary data in support of a future R01
proposal.

Public health relevance
Project Narrative (Public Health Relevance) Fatty liver affects ~90% of heavy drinkers. This project uses microscopy, biochemistry, mass spectrometry, and rodent models of ALD to determine the interplay between lipolysis and lipophagy in the hepatocellular breakdown of lipid droplets. The goal of this work is to gain a comprehensive understanding of hepatic lipid catabolism in order to support the development of pharmacotherapies that mitigate fatty liver progression.